Novel Assessment of the Role of Surgery in Recurrent Diverticulitis

PROJECT SUMMARY/ABSTRACT
Diverticulosis of the sigmoid colon is a significant burden to the US health system. Complications lead
to substantial morbidity and mortality. In 2004, diverticular disease was responsible for 313,000
hospitalizations, 1.9 million ambulatory care visits, and 3365 deaths in the United States. Indications for
surgical management of chronic or recurrent diverticulitis are poorly understood.
A number of studies have revealed that there is minimal mortality benefit to elective surgery for
diverticular disease. Because of this, traditional surgical outcomes, such as 30-day survival, wound
morbidity and in hospital complications are poor metrics to analyze this problem.
This proposal describes a career development plan for a colorectal surgeon that will enable me to use
my 75% protected effort to develop expertise in qualitative analysis, patient reported outcomes, comparative
effectiveness, and analysis of longitudinal data. The research specific aims are: 1) to investigate alignment
between the goals and expectations of patients and surgeons; 2) analyze the effect of surgery on the function
and quality of life of patients with recurrent diverticulitis; and 3) assess the effect of surgery on health care
utilization, work absenteeism and financial toxicity in recurrent diverticulitis.
The career development plan integrates: a) advanced coursework and individualized mentor-directed
instruction in qualitative methodology, patient reported outcomes, and surgical comparative effectiveness
techniques, b) participation in local/national seminars and conferences to advance expertise in qualitative and
quantitative aspects in development of patient reported outcomes, c) a multidisciplinary mentored research
experience, and d) a highly supportive research environment. This environment includes the Center for Health
Services Research, the Center for Surgical Quality and Outcomes Research, an AHRQ-funded Evidence-
based Practice Center, a top-ranked Peabody School of Education, a Masters in Public Health program, and
the Vanderbilt University Department of Surgery.
Overall, this career development award will advance my ability in qualitative methods, patient reported
outcomes and comparative effectiveness research by providing both didactic and experiential education under
the supervision of proven mentors. We will generate important data on functional and quality of life outcomes
for patients with diverticular disease. Importantly, this award provides critical support to seamlessly transition
toward future independently funded studies that use patient reported outcomes to conduct comparative
effectiveness studies to better understand the role of surgery in chronic disease states, including both
diverticular disease and other disorders.

Public health relevance
PROJECT NARRATIVE Recurrent diverticulitis is a prevalent and costly disease for which there is substantial equipoise regarding treatment due to the lack of high quality data. This proposal will evaluate both the decision to undergo surgery and the natural history of Patient Reported Outcomes for patients with recurrent diverticulitis. The results will better inform both patients and physicians faced with the management of recurrent diverticulitis.